Administrative and Research Support Core

Core A: Administrative and Research Support Core The goals of the Administrative and Research Support Core of the Michigan NIA P30 Center (MiCDA) are to: ? plan, coordinate, review, and manage the Center's activities, including travel, ? oversee the pilot grant program, ? manage MiCDA's Advisory Committee, and ? provide affiliates with computing, data-related, and web support services. Core A services span MiCDA's five other Core activities, providing: leadership for faculty enhancement activities; information exchange among MiCDA's administrators, Core leaders, and Advisory Committee; oversight of the pilot project program; research infrastructure support through computing, web, and data services; and travel and event planning services for meetings, conferences, and workshops that create opportunities for collaboration on and generation of new research on the demography and economics of aging.

Public health relevance
The Administrative Support Core provides essential services to MiCDA affiliates and in doing so stimulates new research on chronic disease and disability; life course determinants of health and wellbeing in later life; aging, genetics, and social science; and the economics of savings and retirement. Findings contribute to our understanding of the health and wellbeing of older adults in the aging US population and internationally.